The Kansas Department of Agriculture's Implementation of the Animal Feed Regulatory Program Standards through a Cooperative Agreement

Project Summary The Kansas Department of Agriculture aims to help create a national, fully integrated feed safety system by implementing the Animal Feed Regulatory Program Standards (AFRPS). Through self-assessment, training, auditing, enforcement, and outreach the Agricultural Commodities Assurance Program (ACAP) will improve upon their existing structure by creating a risk-based feed safety program. The Kansas Department of Agriculture Laboratory (KDAL) serves as the primary testing lab for ACAP and is an integral part of the implementation of Standard 10 within AFRPS. KDAL will expand its capabilities and provide data of sufficient quality to the feed program that could be used in enforcement situations. Laboratory accreditation to ISO/IEC 17025:2005 establishes a complete quality system to ensure quality analytical results are put forth. The accreditation attests to the competency and technical capabilities of a laboratory to perform certain tasks and supports traceability of data generated. The collaboration between ACAP and KDAL will play an integral role in achieving an integrated national feed safety system.

Public health relevance
Project Narrative Relevance By participating in this cooperative agreement, the Kansas Department of Agriculture (KDA) aims to successfully implement the Animal Feed Regulatory Program Standards. Additionally, the Kansas Department of Agriculture Laboratory (KDAL) will create and implement a quality system consistent with the principles and requirements of ISO/IEC 17025:2005. ISO/IEC 17025:2005 will attest to KDAL’s competency and technical capabilities to perform tasks and support traceability of data generated. Implementation of these standards means KDA will maintain best practices for a high-quality animal feed regulatory program. The Agricultural Commodities Assurance Program aims to ensure a safer feed supply for the State of Kansas without adversely impacting the manufacturers of animal feed in Kansas.